ACTG 300--ZIDOVUDINE &LARNIVUDINE VS MONOTHERAPY ZDV IN HIV INFECTED CHILDREN

This study is designed to determine the comparative effectiveness of zidvudine and larnivudine and 3TC versus the better of ddI monotherapy of ZDV/ddl combination, in respect to progression of HIV disease, weight/growth velocity, or development of neurologic or neuro-psychologic complications of HIV infection. In addition, safety and tolerance of 3TC/ZDV will be evaluated in symptomatic children who have not had more than eight weeks of prior ZDV exposure.